Understanding the link between sleep deprivation and oxidative stress

Project Summary
We discovered that sleep deprivation causes accumulation of free radicals (reactive oxygen
species, ROS) and oxidative stress in the gut of flies and mice. This is in large part responsible
for the premature death seen when sleep is very low. Here we propose to study what occurs
upstream and downstream of ROS accumulation. Specifically, we will ask how the lack of sleep
leads to increase in ROS, and how ROS then causes organismal death. Together, this will bring
us closer to fully understanding what sleep does for health and longevity. This is an important
problem as so many of us are chronically sleep deprived, and sleep deprivation causes or
exacerbates a whole slew of diseases.

Public health relevance
Project Narrative Sleep disorders are common in the general population, with almost one hundred sleep disorders described to date (e.g. sleep apnea, narcolepsy, advanced and delayed sleep phase syndromes), making it imperative to understand this behavior in order to alleviate sleep-related health problems. Estimated 40-70% of people are sleep deprived because they either cannot sleep (have insomnia), or do not sleep (lifestyle limitations and choices). The fly has been at the vanguard of efforts to understand many previously mysterious biological phenomena and there is every reason to believe that this role will be revisited in investigating sleep (for instance, factors that are linked to familial sleep disorders in humans – Period and Casein Kinase 1- had their homologues discovered and first characterized in Drosophila).